Cell death proteins as inflammatory mediators in sepsis

Sepsis is a significant public health issue in the United States, killing 300,000 people each year and generating
over $60 billion in costs to Medicare beneficiaries. Because we do not fully understand how infection triggers
the inflammatory dysregulation seen in sepsis, no targeted therapies for sepsis are clinically available. Patient
treatments are limited to antibiotics directed against infection and supportive care for organ failure. Cell death
signaling pathways, the mechanisms that control cell fate in response to environmental stimuli, are distributed
throughout mammalian tissue and are a foundational component of host defense against invading pathogens.
During infection, these pathways activate immune responses, clear infected cells, incite tissue damage, and
promote inflammation. This proposal seeks to understand how cell death signaling pathways contribute to the
inflammatory dysregulation that typifies sepsis. This will be done by assaying activity of these pathways under
conditions of infection in both immune and non-immune tissue. Samples collected from septic human patients
will be analyzed for cell death signaling pathway activity and data will be correlated with clinical variables.
Insights gained from these observations will be used to direct mechanistic studies aimed at determining how
these pathways are regulated during sepsis. Both in vitro and in vivo techniques will be utilized when
experiments cannot be performed in human patients. Cultured human cell lines will be infected and analyzed in
vitro, and the effects of cell death signaling pathway inhibition will be measured in septic animals. Results from
this proposal will better define the mechanisms through which infection unleashes dysregulated inflammation in
sepsis and offer a greater understanding of how core cellular homeostasis and defense machinery functions
during critical illness. This knowledge stands to produce novel therapeutic strategies and targets for a deadly
disease process that continues to put tremendous strain on modern healthcare systems.

Public health relevance
Programmed cell death signaling pathways are integral components of the host response to infection, yet how they contribute to inflammation during sepsis remains incompletely defined. This program aims to define mechanisms by which cell death signaling pathways contribute to septic inflammation and inflammatory dysregulation, thereby identifying therapeutic targets and strategies for a lethal and highly prevalent disease process.